Chemical Biology of HIV-1 Nef

Summary. Existing antiretroviral drugs do not clear HIV-1 latent reservoirs, underscoring the urgent need for
new therapeutic strategies. The HIV-1 Nef accessory factor is an attractive target for drug development because
of its critical roles in the HIV-1 life cycle and immune system escape. Our group has discovered novel small
molecules that bind directly to Nef and block many of its functions, including enhancement of viral infectivity and
replication in donor PBMCs. Importantly, our Nef inhibitors rescue cell-surface MHC-I expression in latently
infected, patient-derived CD4+ T-cells, enabling recognition and killing by autologous CTLs. Thus, Nef
inhibitors represent an innovative approach to antiretroviral therapy that may provide a path to eradication of
viral reservoirs. Our most promising class of inhibitors (hydroxypyrazoles) bind tightly to their Nef protein target
in vitro and are active against multiple Nef functions in cell-based systems without cytotoxicity. Experiments
proposed here will leverage these compounds as chemical probes to shed new light on Nef functions while
unraveling their mechanism of action with the following Specific Aims: Aim 1. Map the binding site for hydroxy-
pyrazole Nef inhibitors by X-ray crystallography. Preliminary and published data strongly suggest that hydroxy-
pyrazole Nef inhibitors, which disrupt multiple Nef functions, may perturb the structure of functional Nef-effector
complexes. X-ray crystallography of inhibitors with Nef alone and in complexes with host cell effector proteins
will be used to test this idea and identify inhibitor binding sites. Aim 2. Identification of Nef residues essential for
inhibitor action through in vitro selection. Using PCR-based saturation mutagenesis, we have replaced every
codon in the Nef core region with each of the 64 nucleotide triplets in the context of HIV-1. CD4 T cells will be
infected with the Nef mutant viral ‘library’ in the presence or absence of Nef inhibitors, and viral supernatants
analyzed by deep sequencing to identify mutations enriched by inhibitor treatment. This method has the potential
to identify Nef regions that allosterically influence inhibitor action in addition to residues directly involved in ligand
binding. Aim 3. Explore the mechanisms by which Nef inhibitors suppress HIV-1 infectivity. Hydroxypyrazole
Nef inhibitors reduce HIV-1 infectivity in TZM-bl reporter cells to the same extent as Nef-deleted viruses. This
Aim will explore the whether Nef inhibitors restore virion incorporation of SERINC proteins and Ezrin, two host
cell restriction factors linked to Nef. We will also pursue Nef inhibitor effects on overall HIV-1 protein composition
by whole-virus proteomics, which has the potential to identify host cell factors that are uniquely incorporated (or
excluded) by Nef inhibition. Aim 4. Investigate the mechanism of Nef inhibitor action on MHC-I downregulation.
This Aim will explore the effect of Nef inhibitors on crystal structures of Nef in complexes with the MHC-I cyto-
plasmic tail and the AP-1 µ1 subunit, interactions essential for immune escape. Inhibitor effects on Nef interac-
tions with MHC-I and AP-1 will also be explored in cells using bimolecular fluorescence complementation (BiFC).
These studies will clarify the mechanisms by which Nef inhibitors restore CTL responses to HIV infection.

Public health relevance
Project Narrative. The proposed studies are focused on new approaches to HIV/AIDS drug development by targeting an HIV-1 accessory protein (Nef) essential for AIDS progression. Successful completion of the proposed work will provide essential new insights regarding the mechanism of action of promising small molecule drug candidates that block multiple Nef functions critical to the HIV-1 life cycle. Nef inhibitors show great promise for development as a new class of anti-HIV therapeutics with the potential to clear HIV-producing cells from patients, resulting in a functional cure.